Technology transfer of behavioral economic tasks for assessing alcohol reinforcer pathology: Development and feasibility of a commercially-available tool for clinical practice

PROJECT SUMMARY Alcohol use disorder (AUD) contributes to excessive disability, morbidity, and mortality in the United States. As one of the nation’s leading preventable causes of death, the first line of defense against AUD must be standardized screening provided by the patient’s primary care physician, psychiatrist, and/or counselor. Standardized screening, however, is simply under-performed. Reform proposals call for improved technology for electronic screening to save time and improve standards of care. Moreover, the National Institute of Mental Health’s Research Domain Criteria (RDoC) framework prescribes a focus on defining the underlying functional dynamics of AUD instead of using symptom-based tools as biomarkers for disease. Therefore, the present proposal aims to develop a validated, theoretically-guided tool, which provides clinicians with information beyond AUD symptoms. Reinforcer pathology is a measure of severity derived from the synergy between two distinct decision-making processes, 1) preference for immediately available small rewards (i.e., excessive delay discounting) and 2) over-valuation of alcohol rewards (i.e., high behavioral economic demand). Paramount to this proposal, decades of research have concluded that delay discounting and demand are highly correlated with alcohol use severity and important predictors of AUD treatment success. In order to develop a feasible and acceptable reinforcer pathology-based mobile tablet application, BEACON, for use in the clinic, the present proposal aims to recruit clinicians to provide feedback via focus group sessions (Aim 1), and integrate the BEACON into their practice (Aim 3a), executed by BEAM Diagnostics, Inc. Development, iteration, and maintenance of the app, including the user-interface and back end, secure database, score calculation, and associated web portal will be built and maintained by Virginia Tech Carilion Research Institute (Aim 2). A total of three tool prototype iterations, based on clinician focus group feedback, will be administered to clinic patients throughout the testing period to collect reinforcer pathology scores and patient feedback (Aim 3b; BEAM Diagnostics, Inc). This reinforcement pathology assessment tool is innovative given its propensity to by-pass self-report of past drinking behavior AUD symptoms and prospectively predict severity based on a theoretical framework, making this Phase I STTR application both timely and necessary.

Public health relevance
PROJECT NARRATIVE Alcohol misuse and alcohol use disorder (AUD) are major contributors to disability, morbidity, and mortality, yet the current standardized screening measures in clinical practice are under-performed and test only symptoms of past behavior. Instead, and in response to National Institute of Health’s call for increased translation of theoretically-based screening tools that examine core functions of AUD, the reinforcer pathology framework examines an individual’s decision-making processes about alcohol providing the clinician with more information about patient AUD severity and prospective risk. The current proposal seeks to develop and test the feasibility of a reinforcer pathology mobile tablet application to rapidly assess AUD severity and risk, providing improved screening of vulnerable patients.